Exploring Wnt-Fzd signaling specificities

Project Summary/Abstract:
Cell-cell communication lies at the heart of evolution of multi-cellular life: cells send specific signals to instruct
their neighbors to adopt fates distinct of their own. An important class of developmental signals is encoded by
the Wnt gene family. Wnt proteins interact with their cognate receptors of the Frizzled (Fzd) family to control
countless developmental processes, from establishing the polarity of a single cell within a tissue to specifying
the anterior-posterior body axis of an organism. Deregulation of Wnt signaling can have catastrophic
consequences, including embryonic lethality, birth defects, and disease. With their diverse and potent activities
in development and stem cells, Wnt proteins hold great promise as potent tools in cell and tissue engineering.
The long-term objective of our research is to gain a better understanding of how Wnt proteins and their
downstream signaling events influence cell fate decisions, and thereby advance technologies and treatments
that specifically target Wnt signaling. Over the past years, we have made important contributions to the
development of Wnts as research-grade reagents to manipulate human pluripotent stem (hPS) cells and
generate cell populations with potential therapeutic value. However, significant challenges need to be
addressed before the full potential of Wnts as therapeutics can be realized. In particular, despite their potent
activities, many Wnt proteins remain difficult to isolate in a biologically active and stable form. Furthermore,
with 19 Wnts and over 20 Wnt receptors (including Fzd1-10, Lrp5/6, Ror1/2, etc.) encoded in the mammalian
genome, it is unclear how signaling specificity is established. Finally, many current attempts to target Wnt
signaling in clinical settings are highly non-specific and produce complications and adverse side effects.
The goal for the next five years is to leverage an innovative technology developed in our laboratory that utilizes
engineered Wnt agonists, called Wnt mimetics, which exhibit superior biochemical properties compared to
native Wnt proteins. These Wnt mimetics will be tested for their effects in several settings, including hPS cell
self-renewal and differentiation, organoid cultures and in whole animals (mice). Furthermore, the proposed
research will explore a new paradigm for how Wnt signaling specificity is established in vivo, and thereby
enable the development of tools and approaches that pinpoint individual Wnt signaling pathways. These
experiments will allow us to test our hypothesis that selective engagement and activation of individual Wnt
receptors and receptor complexes trigger distinct signaling outputs and biological effects.
The proposed research will significantly advance the field of stem cell research and tissue engineering by
establishing new tools and methods to manipulate Wnt signaling in vitro and in vivo. With its abundant roles in
human disorders and diseases, a better understanding of Wnt signaling is essential for the development of
novel therapies for currently incurable diseases.

Public health relevance
PROJECT NARRATIVE Wnt signaling is a critical regulator of development, and de-regulation of this pathway results in severe developmental defects, loss of tissue homeostasis and cancer. The proposed research will advance our understanding of Wnt signaling by generating and characterizing new tools to manipulate this pathway in human pluripotent stem cells, organoid cultures and whole animals. The long-term goal of these studies is to gain a better understanding of how Wnt signaling controls embryonic development, thereby enabling strategies for the generation of mature cells types, tissues and organs.